Admin Core

PROJECT SUMMARY: CANCER CENTER ADMINISTRATION
Sylvester Comprehensive Cancer Center (Sylvester) Administration (SA) operationalizes Sylvester’s five-year
Strategic Plan (SP) by developing and maintaining an efficient research infrastructure that fosters
collaboration, communication, diversity, and cancer research excellence. The administrative support provided
by a cohesive, highly trained administrative staff has contributed to a steady growth in the peer-reviewed
funding, high-impact publications, faculty recruitments, collaborative research and overall capabilities of
Sylvester, a recently NCI-designated cancer center. Dorothy Graves, PhD, Associate Director Administration
and Sylvester Assistant Vice President, leads a dynamic and skilled administrative team that supports the
Cancer Center Director, other Sylvester leadership, and a total of 148 Cancer Center members in their mission
to reduce the human burden of cancer in Sylvester’s diverse South Florida catchment area (CA). SA provides
oversight and management of all research administrative areas and activities through the following specific
aims to: 1) Manage and support all aspects of the CCSG, 2) Facilitate the development and execution of
Sylvester’s five-year SPs, 3) Facilitate collaborative, transdisciplinary, and CA-relevant science across the
Center, 4) Provide effective oversight and management of Sylvester financial resources, space, and facilities
and 5) Advance Sylvester education and training, and community outreach and engagement activities,
supporting the creation of a more diverse workforce. During the reporting period (6/1/18–5/31/23), SA grew
broadly, from 59 to 105 staff, to support the operational, non-clinical research needs of the growing and
maturing cancer center and the needs of the growing community it serves. SA was able to expand its services
and provide Sylvester members with an increasingly robust, cancer-focused infrastructure supporting 44 new
member recruits and an operational budget that grew by 51% during the reporting period. Sylvester members
have garnered $27.9M in peer-reviewed funding, that includes funding from 58 multi-PI grants (as of 5/31/23),
and $12M in NCI research funds. Trainees and early career faculty received 33 training grants, and members
published 1,872 peer-reviewed manuscripts, of which 30% were published in journals with an impact factor
>10. Through the investment of $11.9M in CCSG and Sylvester Developmental Funds, $58.7M in extramural
funding was obtained. SA effectively leverages University of Miami resources such as the Office of Research
Administration, Institutional Review Board, Information Technology, Office of Diversity, Inclusion, and
Community Engagement, Government Relations, Marketing and Communications, and Human Resources to
ensure synergistic relationships, streamlined processes and coordinated administrative support, enabling
Sylvester to accomplish CCSG-aligned growth and success.